Molecular Profiling of Diabetes and its Complications

In the current project, the techniques of classic epidemiology and of genetic epidemiology are being used to identify determinants of type 2 diabetes, its risk factors and its complications. The effects of genetic factors are assessed in other projects (DK069028-24, Genetic Epidemiology of Diabetes and Obesity and DK069094-06, Genetic Epidemiology of Diabetic Complications); the present study focuses on molecular processes that are downstream of genetic factors, such as gene transcription, protein expression and cellular metabolism. Longitudinal studies are being conducted in individuals at high risk for type 2 diabetes in urban Phoenix. Samples are collected for studies of genomic DNA, and these samples are also suitable for studies of epigenetic factors, such as DNA methylation and histone modification. Samples are collected that suitable for RNA extraction and for large scale studies of protein levels and metabolomics. Information on family membership is collected for inclusion in family-based analyses.

Recent analyses of genome-wide transcription in skeletal muscle tissue have shown that a small number of transcripts have a clearly bimodal frequency distribution; the vast majority of these are accounted for by the effect of a genetic polymorphism in close proximity the region encoding for the transcript. Analyses using empirical identity by descent estimates from dense genotypic data suggest that a large amount of the heritability in gene expression is due to the action of variants within or near the region coding for the transcript. Large scale genome-wide transcription profiles are also being measured in peripheral blood samples in collaboration with investigators from University of Texas-Rio Grande Valley. Diabetic complications are also being studied- recently we found that risk factors for peripheral neuropathy are different in diabetic and nondiabetic individuals. Recent comparisons of genotypic and phenotypic divergence among diverse ancestry groups suggest that differential natural selection is not necessary to explain differences in diabetes risk and obesity among ancestry groups. Further analyses of specific transcriptomic patterns is underway to identify specific pathways that may influence disease risk and that may be subject to natural selection. Plasma metabolomic data have recently been obtained and these are being analyzed with respect to inulin sensitivity.

Analyses of the relationship of transcription in peripheral blood samples with diabetes, obesity and related factors are currently in process, as is the assessment of heritability and parent-of-origin effects. Recruitment of additional individuals and families and longitudinal follow-up are also ongoing.